Understanding the Platelet-CD8+ T Cell Interactions in Sepsis

Abstract
Sepsis remains a significant global health threat due to its high mortality rate and substantial
economic burden. Nearly half of septic patients develop chronic critical illness (CCI),
characterized by prolonged organ dysfunction and increased susceptibility to infections. T cell
suppression, particularly CD8+ T cell suppression, is a key driver of CCI. Large gaps in
understanding the pathogenesis of CCI have hindered its early identification and the development
of effective therapies. Our recent work on platelets during sepsis revealed that major
histocompatibility complex class I (MHC-I) antigen presentation and T cell regulating pathways
are among the most significantly altered pathways in platelets. We further discovered that
platelets actively internalize, degrade, and cross-present antigens via MHC-I to CD8+ T cells.
Using platelet lineage specific MHC-I deficient mice, we found that platelet MHC-I plays a major
role in CD8+ T cell suppression during sepsis. This research program further investigates the
clinical impact of platelet mediated CD8+ T cell suppression and explores the mechanism of MHC-
I mediated platelet–CD8+ T cell interactions in sepsis-associated CCI. The goals for our
laboratory's research program over the next five years include the following: 1) determining
whether platelet–CD8+ T cell aggregates are present in sepsis patients and whether they are
associated with adverse outcomes; 2) characterizing which CD8+ T cell subsets are involved and
how their functions differ from those of platelet-free CD8+ T cells; and 3) elucidating the structure
and molecular mechanisms underlying these platelet-T cell interactions and their impact on CD8+
T cell function during sepsis. This research program addresses a critical gap in our
understanding of sepsis pathogenesis. By investigating the previously unexplored relationship
between MHC-I mediated platelets and CD8+ T cells, we aim to pave the way for improved long-
term management strategies for sepsis.

Public health relevance
Narrative Sepsis accounts for 20% of global death. Nearly half of septic patients develop chronic critical illness (CCI), characterized by prolonged organ dysfunction and recurrent infections. CD8+ T cell suppression is a key driver in CCI. Our recent work identified a critical role of platelets in CD8+ T cell suppression during sepsis. We will examine the role of platelet-CD8+ T-cell interactions in CCI progression, outcome and its mechanism.